Defining developmentally regulated retroelement-based mechanisms to better understand and treat their dysregulation in disease.

Nearly half of all mammalian genomes originate from mobile sequences and ancient retroviruses called
RetroElements (REs). REs consists of tens-of-thousands of nearly identical repetitive copies per RE-family and
have been historically considered “Molecular Parasites” or “Junk DNA” as most are immobilized by mutations
and epigenetic silencing. However, rare instances of gene disruption following RE integration have led to an “US
versus THEM” model that fails to reflect symbiotic relationships developed over millions of years of co-
evolution. This is best demonstrated by the well-known but poorly understood phenomenon of “RE-reactivation”
in mammalian preimplantation embryos, in which thousands of related REs express simultaneously at distinct
stages. REs are essential for development, as their disruption is embryonic lethal. Some REs have maintained
regulatory features that influence expression, structure, and function of nearby genes and RE-signatures tightly
overlap with events that are unique to preimplantation embryos, including zygotic genome activation, totipotency,
reprogramming and pluripotency, supporting the hypothesis that RE-reactivation was perhaps the innovative
catalysts for promoting conserved embryo specific programs through domestication of viral functions and rewired
gene networks. In support, our single cell technologies and preimplantation RNA-Seq analysis to assess RE
function revealed highly conserved expression patterns of RE families across 8 mammalian species. To study
these, we developed an embryo editing technology (CRISPR-EZ) to delete 5 specific RE insertions in mice, each
resulting in unique developmental defects. These findings revealed the first essential retrotransposon in
mammalian development and established reactivation as part of “Normal Development” and shifting our view on
“Junk DNA”. While silenced in most tissues, unintentional RT reactivation is commonly observed (and largely
ignored) during epigenetic breakdown occurring in aging, autoimmunity, neurodegeneration, and cancer.
Therefore, the goal of this proposal is to characterize RE regulatory networks and mechanisms that ensure
proper development and leverage this information to explore the therapeutic potential of “synthetic RE-
reactivation” to re-engage beneficial “emergent properties” in epigenetically compromised cells or block RE-
Signatures in compromised cells to ameliorate or even reverse pathologies. This proposal pioneers a
combination of comparative biology, genome editing and parallel in vivo / in vitro strategies using CRISPR/CAS9
variants and consists of three interconnected but independent aims. We use a human centric criterion to select
RE candidates to 1) characterize conserved RE-mechanisms in development through humanized mouse
models, 2) define RE regulation through a combined in vitro/in vivo CRISPR strategy and 3) assess the
therapeutic potential of RE modulation in adult and diseased cells. Together, our findings will provide an atlas of
REs that have been domesticated by host genomes as a reservoir of genetic innovation and how they can be
further harnessed to study human embryo development and used as a therapeutic tool to improve human health.

Public health relevance
Nearly 50% of the human genome is made up of mobile elements and ancient retroviruses called RetroElements (REs) that are present in thousands of nearly identical copies. As REs are paradoxically expressed during preimplantation development and recent findings reveal that RE reactivation is precise and essential for mammalian development, this proposal seeks to establish the functional importance and mechanistic basis of RE reactivation through gene editing, comparative biology and novel CRISPR based screening. Notably, REs are unintentionally reactivated in aging, autoimmunity, neurodegeneration and cancer and we predict that by cataloging RE-based mechanisms in embryos and identifying RE-regulation, we can therapeutically manipulate REs in adult tissue to mitigate or potentially reverse disease states.